The role of CEACAM1 in CMV pathogenesis in the human placenta

DESCRIPTION (provided by applicant): Human cytomegalovirus (CMV) is the leading viral cause of birth defects in the United States. Prenatal infection occurs in 1-3% of births and can lead to intrauterine growth restriction and permanent birth defects, including mental retardation, neurological defects, and deafness. Temporary symptoms of congenital disease can result from lack of nutrient and oxygen transport to the fetus caused by impaired placental development and function. In vitro studies from our group have shown that this impairment results from poor invasion of the uterine wall by cytotrophoblasts (CTBs) and focal changes in uterine vascular remodeling. CMV-infected placental cells alter their expression of molecules required for invasion, migration, and cell-cell and cell-matrix adhesion. Our recent work has revealed that CMV infection alters the expression of proteins associated with hypoxia-inducible angiogenic factors. Importantly, a physiological balance between pro- and anti-angiogenic factors control placental development and an alteration of this balance directly impairs cell differentiation/ invasion. CTBs express one of these regulators during invasion-carcinoembryonic antigen-related cell adhesion molecule 1 (CEACAM1)-a member of the immunoglobulin superfamily. CEACAM1 acts as an effector of vascular endothelial growth factor during angiogenesis and its expression is upregulated in response to hypoxia. Interestingly, a soluble form of CEACAM1 (sCEACAM1) produced by CEACAM1- expressing cells inhibits angiogenesis in vitro and in vivo. Our studies have shown that CMV infection induces CEACAM1 in neighboring, uninfected endothelial cells, but not in infected cells, through a paracrine effect driven by viral infection. Increased secretion of CEACAM1 from CMV-infected cell cultures and recombinant sCEACAM1 severely impair endothelial cell migration, a key step in angiogenesis. Our central hypothesis is that sCEACAM1 is an important paracrine mediator of viral pathogenesis through its inhibition of local angiogenesis and/or CTB differentiation/invasion. Importantly, CMV infection induces the expression of multiple CEACAM1 isoforms, which are likely glycosylated and secreted. The effect of CEACAM1 function might depend on a combination of isoforms with varying ratios, presence or absence or sCEACAM1 and the nature of various glycoforms. The goal of the current proposal is to determine the specific functions of multiple sCEACAM1 isoforms from CMV- infected specialized cells from the uterine- placental interface. Accordingly, we propose the following Specific Aims: Aim 1. Determine the effects of sCEACAM1 from CMV-infected endothelial cells on angiogenesis. Aim 2. Determine the role of CEACAM1 in controlling CTB differentiation and invasion. Studies in this application seek to identify the underlying molecular processes dysregulated in angiogenesis and vascular remodeling in congenitally infected placentas, and increase our understanding of the molecular mechanisms that undermine development and could have broad clinical application to vascular biology. PUBLIC HEALTH RELEVANCE: Congenital cytomegalovirus (CMV) infection is the leading viral cause of birth defects in the United States. Primary infection in pregnant women frequently leads to birth defects including neurological disorders and deafness. This project addresses molecular mechanisms of viral damage that impairs functions of the human placenta and could identify novel proteins with clinical importance for development of diagnostic and therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Congenital cytomegalovirus (CMV) infection is the leading viral cause of birth defects in the United States. Primary infection in pregnant women frequently leads to birth defects including neurological disorders and deafness. This project addresses molecular mechanisms of viral damage that impairs functions of the human placenta and could identify novel proteins with clinical importance for development of diagnostic and therapeutic strategies.